HORNET Center for Autonomic Nerve Recording and Stimulation Systems (CARSS)

PROJECT SUMMARY FINAL – U41 Supplement
Despite a wide-ranging interest in performing clinical research for bioelectronic medicine applications, there are
no available open-architecture and open-source implantable systems for autonomic nerve stimulation and
recording. As a result, clinical researchers face significant technical, regulatory, and financial hurdles in getting
access to the implantable neuromodulation technologies that are required for performing these clinical studies.
There are several clinical closed-loop implantable neuromodulation systems presently available and they have
been helpful in supporting clinical research. However, in their current form, none are suitable for the bioelectronic
medicine applications, as they lack key functional modules for accessing the autonomic nerves; moreover, many
of them use closed architectures (e.g., the use of custom ASICs instead of commercial over-the-shelf
components) and proprietary software.
Therefore, the overall objective of this HORNET Center for Autonomic Nerve Recording and Stimulation
Systems (CARSS) is to develop an open-architecture and open-source implantable system for autonomic nerve
stimulation and recording. In this administrative supplement, we will perform short and long term validation of
functionality and safety of system components in large and small animal models. The CARSS system includes
an external charger and controller, implantable pulse generator, and an assortment of interoperable and
implantable leads for stimulation and sensing.
The stomach and duodenum were selected for long term validation, consistent with the focus of the NIH
SPARC program. We will test in pig the implantable pulse generator, vagal nerve and sacral nerve stimulation
leads, electrocardiographic (ECG) leads, electromyographic (EMG) leads, and accelerometer-based motion
sensing (AMS) leads. Our remaining leads, including the helical cuff targeting nerves less than 1 mm in diameter,
mechanical sensing leads, and electrochemical sensors, will be tested in rats acutely and then chronically. The
electronics module for the CARSS system will be connected externally to the leads to perform stimulation and
sensing.

Public health relevance
PROJECT NARRATIVE FINAL – U41 SUPPLEMENT The objective of this Administrative Supplement is to perform short- and long-term validation in large and small animal models of the functionality and safety of our open-architecture and open-source implantable system for autonomic nerve stimulation and recording system. This supplement is related to parent award U41 NS129514 “HORNET Center for Autonomic Nerve Recording and Stimulation Systems (CARSS)” which aims to develop the system to support clinical research for bioelectronic medicine applications. Testing will include both external and implanted CARSS system components: (1) external charger and controller, (2) implantable pulse generator, and (3) an interoperable assortment of implantable leads for stimulation and sensing.